Migration and Place of Settlement and Child Health and Development: U.S.-born children in Mexico and United States

Project summary: Children of Immigrants in Mexico and the United States
More than half a million U.S.-born children currently live in Mexico. Research has largely
overlooked this important population of U.S. citizen children, particularly in comparison with
children of immigrants who remain in the United States. This study will provide a detailed socio-
demographic portrait of the large binational population of Mexican American children of
immigrants living in the United States and in Mexico. Mexican and U.S. census data from 2019-
2020 will be combined and analyzed to describe and compare the socioeconomic conditions
faced by children of Mexican immigrants born in Mexico who live in the United States and
children of Mexican immigrants born in the United States who live in Mexico. Socioeconomic
conditions include family and household structure, child’s enrollment in school, children’s access
to health care, and household economic resources. U.S.-born children in Mexico who are there
because they accompanied a deported parent will be identified using new questions on the
2020 Mexican Census about the parents’ reason for return to Mexico. The study will estimate
the extent to which U.S.-born children in Mexico are there due to de facto deportation and how
the socioeconomic conditions they face in Mexico compare to those faced by children at risk of
de facto deportation in the United States. The research will give scholars, policymakers, and
practitioners up-to-date, valid estimates of the size and characteristics of the large, binational
population of Mexican American children of immigrants living in Mexico and the United States.

Public health relevance
This research will contribute basic knowledge about size of and socioeconomic conditions faced by the large population of Mexican American children of immigrants living in Mexico and the United States. By comparing U.S. citizen children in Mexico to children of Mexican immigrants in the United States, we will deepen our understanding of how migration and place of settlement impact child health and development.